ALVEOLAR PERMEABILITY AND LUNG DISEASE

The research will investigate physiologic effects of surfactant replacement therapy in premature lambs. It will also study the pathogenesis of severe permeability lung edema in rabbits and measure lung water accumulation and distribution, alveolar epithelial permeability and alveolar surfactant activity in this model. The premature sheep will have extracted cow lung lipids and artificial phospholipids instilled into their lungs before breathing or aerosolized after 1 or 4 hours of mechanical ventilation. Animals will be ventilated for 72 hours with monitoring of systemic and pulmonary pressures and blood gases. Fetal alveolar liquid volumes and alveolar surfactant and lung pressure volume curves will be measured twice during the first 2 hours of breathing and at the end of the experiment. These studies will define important effects on lungs of animals in a controlled situation which will help define appropriate agents, methods of delivery and possible complications in future human use in hyaline membrane disease. In an adult rabbit model of pulmonary edema caused by continued air embolism. Using multiple radiolabeled tracers distribution of lung water and alveolar epithelial permeability will be measured. These actions and lung surfactant activity will be temporally related to the progression of the lung injury. A trial of exogenous surfactant therapy replacement will be made to determine if it can improve lung function as it does in premature lambs. The definition of changes in lung water, alveolar epithelial permeability and alveolar surfactant activity during progression of experimental permeability edema aims to increase understanding of the pathogenesis of adult respiratory distress syndrome in humans with the expectation of determining possible therapeutic strategies for different stages of the process.